Johns Hopkins RDRCC Administrative Core

PROJECT SUMMARY
The primary objectives of the Administrative Core of the Johns Hopkins Rheumatic Diseases
Resource-based Core Center (RDRCC) are to integrate all scientific and enrichment activities of
the Cores, maintain communication between the Cores and with the research base, and provide
budgetary management and oversight, all within the context of the overall Divisional and
institutional clinical/ translational research framework. The RDRCC and its Administrative Core
is led by Drs. Antony Rosen and Clifton Bingham (as Co-Directors). Their complementary
research approaches from the opposite ends of the research spectrum (laboratory and clinical
respectively) underscore the Center’s ability to enable research along the entire translational
research continuum. The Specific Aims of the Administrative Core of the RDRCC are to:
1) Oversee, coordinate, and actively manage the logistic and financial aspects of three Scientific
Cores (Core B—Precision Medicine Data Integration, Core C—Sample Processing and
Immunoassay Research, SPIRE; and Core D—Data Science); 2) Continually work to decrease
barriers to effective, cross-disciplinary interaction amongst investigators focused on the
rheumatic diseases; 3) Use innovative approaches to interface with the Divisional Discovery
Fund program and institutional resources to maximize RDRCC Core utilization by novel projects
focused on the rheumatic diseases; 4) Foster the careers of junior investigators; 5) Initiate and
support innovative collaborations between Center investigators and investigators new to
rheumatic diseases with complementary expertise and interests; 6) Coordinate a program of
enrichment activities to enhance research methodological literacy and the overall intellectual
environment across disciplines. Each of these components will work together through the
Administrative Core to enable research in the Rheumatic Diseases to thrive and expand.